Predictive and Diagnostic Radiomic Signatures in Non-Small Cell Lung Cancer (NSCLC)on Immunotherapy

PROJECT SUMMARY
We propose to identify novel radiomic signatures of anti-programmed death ligand 1 (PDL1)/PD1 therapy
response for non-small cell lung cancer (NSCLC) and evaluate how these signatures can augment established
biomarkers. Immunotherapy has been rapidly integrated into NSCLC management due to dramatically improved
response rates compared to conventional cytotoxic therapy and is now also accepted as 1st line therapy for
selected populations. While stratification of patients based on tumor expression of PDL1 has improved therapy
response rates, up to 30-40% of NSCLC patients still fail 1st line therapy with these agents, suggesting that new
strategies are needed to more accurately select patients likely to benefit. While a radiomic approach has yet to
be fully studied in the context of NSCLC immunotherapy, early evidence, including our preliminary data, suggests
that radiomic features extracted from routine computed tomography (CT) capture important characteristics of the
tumor phenotype, including vascular structure, intra-tumor heterogeneity, and immune infiltration of the tumor
microenvironment, which could provide a powerful phenotypic approach to augment established biomarkers for
anti-PDL1/PD1 therapy. We propose to perform the largest radiomics study conducted to date on immunotherapy
for NSCLC, leveraging CT data from an existing institutional database (n=2095 patients) which includes
biocorrelates of patients treated with anti-PD1/PDL1 therapy agents, and an on-going ECOG-ACRIN multi-
institutional trial (n=846) to be used for independent validation. By pursuing this research, we will therefore aim
to address this fundamental question: Can radiomic signatures augment established biomarkers, such as
PDL1 expression, in predicting which patients are likely to benefit most from anti-PD1/PDL1 therapy?
While most radiomics studies to date have focused on anti-PD1/PDL1 therapy for NSCLC in the non-1st line
setting, we will seek to discover radiomic signatures specifically for 1st versus later line of immunotherapy, and
we will examine such signatures both at baseline, prior to the initiation of therapy, as well as longitudinally during
the course of therapy in association to tumor response, progression-free and overall survival. We will further
correlate these signatures with known biomarkers of anti-PDL1 therapy response, including PDL1 expression,
tumor mutational burden (TMB), circulating (ct)-DNA, and tumor-infiltrating lymphocytes (TILS), to better
understand how radiomics can augment these established and emerging biomarkers in predicting anti-
PD1/PDL1 therapy response. To discover these radiomic signatures, we will leverage the Cancer Phenomics
Toolkit (CapTK), an open-source and highly-standardized software developed by our group, and will utilize a
novel radiomic feature standardization approach, allowing us to incorporate CT scans acquired by variable
acquisition. Together, these approaches will result in robust phenotypic radiomic signatures that will enable a
more informed clinical management of patients selected for anti-PD1/PDL1 therapy by identifying more nearly
effective and earlier therapy options.

Public health relevance
PROJECT NARRATIVE We propose a strategy to develop an integrated-diagnostics tool for eventual clinical translation, which will enable enhanced predictive modeling of clinical outcome and diagnostic precision in 1st line immunotherapy for NSCLC, the choice of which has shown to have a large impact on patient survival during the course of cancer management since subsequent lines of treatment are increasingly less likely to be successful. Our radiomics signatures, combined with clinically established and emerging biomarkers, will result in increased precision for the management of patients selected for anti-PD1/PDL1 therapy by more accurately predicting who will benefit from therapy and detect response with more precision and earlier than currently possible.